Mechanism of Dynein-mediated Early Intracellular Trafficking of Human Papillomavirus

PROJECT SUMMARY/ABSTRACT
Human papillomavirus (HPV) infections are responsible for almost all cases of cervical cancer, as well as most
anogenital and oropharyngeal cancers. HPV, a non-enveloped DNA virus, is transported from the cell surface to
the nucleus for genome replication. Recent studies have shown that, rather than exiting directly from the
endosome into the cytosol after endocytosis, incoming HPV remains within a vesicular compartment and moves
along microtubules (MTs) toward the nucleus. Previous research demonstrated that the C-terminus of the HPV
L2 minor capsid protein contains a novel cell-penetrating peptide. This peptide facilitates L2 protrusion through
the endosomal membrane, enabling its interaction with the endosomal sorting complex, retromer, which directs
the virus into a retrograde transport vesicle en route to the Golgi. These processes promote the exposure of L2
protein to the cytosol, thereby facilitating the recruitment of host factors necessary for HPV retrograde transport.
These findings raise important questions about how and when, after endocytosis, the HPV-containing endosomal
compartment interacts with the dynein transport machinery for intracellular movement along MTs across the host
cytoplasm and reach the nucleus. The discovery of dynein adaptors involved in retrograde transport highlights
their roles in the precise recruitment and interaction of dynein with specific membranous compartments. This
has led us to investigate the mechanisms by which dynein is recruited to HPV-carrying endosomal vesicles to
mediate viral transport after endocytosis. Our recent research has uncovered a novel molecular basis for dynein
recruitment to the HPV-carrying endosome. In this process, HPV utilizes the early endosomal small GTPase
Rab5 and its effector Rabankyrin-5 to form a complex that links the HPV-carrying endosome to dynein, facilitating
viral transport along MTs. We propose that HPV repurposes Rabankyrin-5 as a new dynein adaptor, enabling
precise dynein recruitment and physical interactions with HPV-carrying endosomes. This process is linked to the
exposure of HPV L2 protein to the cytosol, which facilitates Rabankyrin-5 recruitment. In Aim 1, we will determine
how HPV infection triggers Rabankyrin-5-mediated virus-dynein association at the endosome, specifically
investigating whether L2 protrusion is required for Rabankyrin-5 recruitment and examining the mechanism of
L2-Rabankyrin-5 interaction. Using live-cell imaging, we will examine the timing of dynein recruitment relative to
L2 protrusion during HPV movement along MTs. In Aim 2, we will investigate whether Rabankyrin-5 acts as a
novel dynein adaptor, directly interacting with dynein and activating its function to promote HPV transport. This
research has the potential to uncover a novel mechanism for HPV intracellular transport during the early stages
of viral entry, involving the spatial and temporal coordination of viral membrane protrusion, endosomal coat
complex formation, and precise dynein recruitment and activation. By advancing our understanding of the cell
biology and molecular virology of HPV infections, this research offers molecular insights that could lead to the
identification of new therapeutic targets and the development of innovative antiviral approaches.

Public health relevance
PROJECT NARRATIVE Human papillomavirus (HPV) is one of the most common sexually transmitted viruses, infecting keratinocytes in the skin and mucosa, and is virtually responsible for causing almost all cervical cancers, as well as most anogenital and oropharyngeal cancers. Our proposed studies aim to elucidate the spatial and temporal organization of host cellular factors and viral proteins involved in HPV intracellular transport during early infection. This research has the potential to uncover therapeutic targets or approaches for future antiviral therapies.